Night Owl Metabolism: Investigating the Impact of Chronotype on Glucose Metabolism in Youth

PROJECT SUMMARY/ABSTRACT
Adolescents commonly develop delayed sleep schedules in normal development related to physiologic
processes, turning into “night owls” (late chronotype). Youth-onset type 2 diabetes (YoT2D) is a disorder with
fast progression and early complications. Delayed sleep timing has been identified as a possible modifiable
risk factor for YoT2D. Although prior studies have linked shifted sleep timing to impaired glucose metabolism,
these studies may not extrapolate to youth with late chronotype as they utilize standard morning testing with
oral glucose tolerance tests (OGTTs), at a time mis-aligned to the typical schedule of an individual with late
chronotype. As glucose tolerance worsens as the day progresses until the middle of the night in healthy
individuals, testing at a time when youth with late chronotype are typically asleep may alter results and lead to
potential mis-diagnoses. Under the expert mentorship of Drs. Sheela Magge and co-mentor, Jonathan Jun, Dr.
Talia Hitt will investigate whether alignment of glucose metabolic testing with chronotype improves glycemic
outcomes and whether alignment of first morning meal timing to chronotype improves post-prandial glycemic
response in youth with late chronotype. The proposed study uses a novel and rigorous randomized cross-over
study design in youth (17-23y) with late and non-late chronotype (n=35 per group) to assess the glycemic
effect of “aligning” an OGTT or first-meal of day to a subject’s chronotype. Both groups will undergo 2 OGTTs
(aligned and mis-aligned with chronotype) to compare glucose tolerance and insulin sensitivity within-subject
(primary outcome) and between groups (Aim 1). Then, youth will also undergo two standardized meals
(aligned and mis-aligned with chronotype) while wearing continuous glucose monitoring to compare post-
prandial glucose excursions within-subject and between groups (Aim 2). A pilot Exploratory Aim 3 (n=12 per
group) will investigate delayed melatonin patterns under dim-light as a potential pathophysiologic mechanism
behind abnormal glucose tolerance in youth with late chronotype on morning OGTTs. This study has potential
implications for both clinical and research practices, as well as meal timing recommendations. It will provide
preliminary data for a future R01 study of the relationships between sleep and circadian rhythm with glucose
metabolism and YoT2D risk. This Career Development Award will develop Dr. Hitt’s training in 4 areas of focus
addressing gaps in her prior research background: (1) longitudinal data analysis, (2) glucose metabolism
mathematical modeling, (3) sleep and circadian phenotyping, and (4) experimental study design. Training
goals will be accomplished through didactic coursework, one-on-one meetings with expert mentors and a multi-
disciplinary advisory team, the study’s research activities, and attendance at scientific and career development
seminars, and conferences. Dr. Hitt will have all needed resources and a supportive environment at Johns
Hopkins. By the end of this 5-year award, Dr. Hitt will have the necessary skills to reach her long-term career
goal to become an independent researcher in the intersection of youth chronobiology and glucose metabolism.

Public health relevance
PROJECT NARRATIVE Later sleep timing has been identified as a risk factor for youth-onset type 2 diabetes, yet adolescents adopt later sleep patterns (chronotype) as part of normal development. Current literature on sleep timing and its relationship to glucose metabolism may not apply to older adolescents and young adults with later chronotype, as morning testing may be mis-aligned with the schedule of these youth, leading to the potential for misleading results and/or misdiagnoses. This project will assess whether delaying the timing of testing for diabetes risk in youth with late chronotype improves testing results both in our research lab and in a real-world setting, to gain a better understanding of the diabetes risk for this understudied population.